Investigating HLA-I as a driver of P. falciparum antigenic diversity

PROJECT SUMMARY
Plasmodium falciparum, the causative agent of the most virulent form of malaria, harbors highly genetically
diverse antigens. While immune selection likely sustains this diversity, the specific immune mechanisms
patterning it and its implications for vaccine interventions remain to be established. In some antigens, dominant
variants differ across geographic regions but alternate little over time. This pattern suggests that antigens may
locally adapt to host populations. We hypothesize that antigens adapt to host population composition at the
HLA-I locus, which governs the ability of the immune system to present parasite peptides to sterilizing cellular
effectors. To test this hypothesis, we first examine infections across a transmission season in an intensively
longitudinally sampled cohort. Using amplicon sequencing of four highly polymorphic parasite antigens and
HLA typing data from hosts, we will test for interactions between specific parasite antigen and host HLA-I
residues that influence infection or clinical outcomes, and furthermore screen HLA-I as a functional driver of
parasite diversity at the population level. Subsequently, we will pair pathogen and host genomic variation
datasets from the MalariaGEN Pf7 database and Allele Frequency Net Database, respectively. Using HLA-I
binding prediction tools, we will compare the peptidomes of potential HLA-I and parasite antigen combinations
and gauge the influence of host and pathogen allele frequencies on predicted binding parameters, testing for
the presence of parasite local adaptation to hosts. Finally, we will use yeast display to perform in vitro
functional validation of changes in HLA-I binding with parasite variation across a large library of peptides. This
project will provide functional insight into the drivers and immunological impacts of parasite variation relevant to
vaccine design.

Public health relevance
PROJECT NARRATIVE Populations of the malaria parasite Plasmodium falciparum harbor remarkable diversity in antigens crucial for vaccine-induced and natural immunity. This proposal investigates the hypothesis that some of this diversity is selected to evade a heritable element of the adaptive immune response: HLA-I presentation. Our findings will demonstrate the extent to which parasite variation may enable escape of sterilizing cell-mediated immunity to key parasite antigens, providing crucial insights for vaccine development.